Recapitulation of the two-cell visual cycle in photoreceptors and its effects on retinoid flux and remedy of toxic retinoid species

PROJECT SUMMARY/ ABSTRACT.
Retinal degenerative (RD) diseases result in a progressive loss of vision, and have a devastating impact on a
patient’s quality of life. Many genetic factors that nucleate these diseases are intricately linked to defects in the
visual (retinoid) cycle. This cycle is necessary for regenerating the essential visual pigment 11-cis-retinal after
it is photoisomerized to all-trans-retinal; errors in this multi-step recycling of all-trans-retinal back to 11-cis-
retinal leads to the buildup of toxic retinoid photo-oxidation products that can kill photoreceptors and the
supporting retinal pigment epithelium (RPE). Few therapeutic options exist for mitigating the damage that is
caused by these photo-oxidation products, especially after cell death in the retina has started to affect quality
of vision.
Normally, the vertebrate visual cycle is distributed across two distinct cell types, the retinal pigment epithelium
and the photoreceptors (i.e., rods and cones). In the functional visual cycle, 11-cis-retinal is initially bound to
opsin proteins within the photoreceptors, where it is then isomerized to all-trans-retinal in the presence of light.
This transformation initiates the phototransduction signaling cascade that travels through optic nerve to the
brain, where the signals are integrated into a coherent visual field. The all-trans-retinal molecules are then
shed by opsins and converted to all-trans-retinol by all-trans-retinal dehydrogenase. The all-trans-retinol is then
transported from the photoreceptors to one of two “helper” cell types- RPE cells that support both rod and cone
function, and Müller cells that solely support cones. Because RPE-linked visual cycle dysfunction has a greater
impact on the retina as a whole, we’ve elected to focus on just the RPE-based visual cycle and not the cone-
exclusive alternative visual cycle. When all-trans-retinol is transported from the photoreceptors to the RPE, the
all-trans-retinol undergoes two key reactions; one catalyzed by lecithin-retinol acyltransferase (abbr. Lrat), and
the other by retinal pigment epithelium-specific 65 kDa (abbr. Rpe65). Lrat catalyzes the coupling of all-trans
retinol to fatty acids, forming stable retinyl ester intermediates. These retinyl esters are subsequently
isomerized and hydrolyzed by Rpe65 to give 11-cis-retinol. 11-cis-retinol is then oxidized to 11-cis-retinal by
11-cis-retinol dehydrogenases and transported back to the photoreceptors for re-use. When the visual cycle is
hindered, all-trans retinal can build up in the photoreceptors, leading to the formation of toxic photo-oxidation
products that cause retinal degeneration.
I intend to expand our knowledge of the visual cycle via engineered expression of Lrat and Rpe65 in the
photoreceptors. In studying how manipulation of retinoid flux in the visual cycle controls the emergence and
progression of RD, we can optimize therapeutic interventions that target the central drivers of retinal disease,
while simultaneously reversing the toxic buildup of retinoids in chronic RD.

Public health relevance
PROJECT NARRATIVE. The visual cycle regenerates key light-sensitive opsin pigments that are essential for vision- these opsins are chemically changed by light exposure, and needs to be rapidly converted back to their initial “dark” state for vision to be sustained in the retina. Impairments of this visual cycle lead to the buildup of toxic molecular intermediates, which kill cells of the retina and potentiate vision loss. In this proposal, I will test if artificially consolidating key visual cycle enzymes into photoreceptor cells can reduce the buildup of these toxic intermediates, exploring their potential in prolonging retinal health and vision.